MGH/HMS Internship in NeuroImaging Analysis

Project Summary/Abstract
In this project, we seek to recruit talented high-school students from low income and minority communities in
the Boston area who are interested in STEM fields. Through a series of paid summer internships, we will train
sets of students on the conduct of biomedical research and encourage them to consider careers in biomedical,
behavioral and clinical sciences. We will partner with the Cambridge chapter of My Brother's Keeper – an
organization committed to disrupting and eradicating the chronic social, mental, economical, and educational
barriers for young people of color – to reach students that would be difficult to recruit without them. Students
will learn to label brain anatomy visible in neuroimaging data, write and publish a scientific paper describing
this work, and make the dataset publicly available. By the end of each year's summer internship, the students
will have been exposed to scientific writing, data analysis, brain anatomy, ethical considerations in conducting
responsible scientific research, the physics of imaging, the clinical disciplines of Neurology and Radiology.
Students will leave the program with established, enduring mentorship relationships.

Public health relevance
Project Narrative In this project we seek to recruit and train minority high-school students who, in many cases, are the first in their family seeking to attend college. Our aim will be to facilitate this goal by giving them a broad array of STEM-related (Science, Technology, Engineering, and Math) training and helping them construct an open- source dataset of labeled brain structures freely available to the public and learning community, then publish a scientific paper at the end of each summer detailing the results and distributing the data.